Optimizing Anti-NMDAR Antibodies for Triple-Negative Breast Cancer Therapy

PROJECT SUMMARY/ABSTRACT
Triple-negative breast cancer (TNBC), which lacks hormone receptor and HER2 expression, is associated with
a high risk of metastatic recurrence and high mortality, necessitating novel therapeutic strategies. A high
percentage of TNBC (>70%) exhibit upregulation of N-methyl-D-aspartate (NMDA) receptor (NMDAR), which
are normally exclusively expressed in the central nervous system, and high NMDAR expression is associated
with perineural invasion and poor prognosis. Despite the potential of anti-NMDAR antibodies to kill NMDAR-
positive cells, cancer patients with spontaneous anti-NMDAR production often experience severe neurological
toxicity manifesting as psychosis and seizures (termed anti-NMDAR encephalitis). However, it remains unknown
whether it is possible to uncouple the anti-tumor effects of anti-NMDAR encephalitis from their toxicity, thereby
establishing a safe and effective therapeutic strategy for TNBC. A key innovation of this proposal is the use of
single-particle cryo-EM to screen for antibody-induced structural alterations in NMDAR, which are necessary
and sufficient for neurological toxicity. We propose a workflow for the identification, characterization, and
validation of anti-NMDAR antibody therapies. First, we will establish an orthotopic mouse model based on
inoculation of 4T1 (triple-negative breast cancer) cells, engineered to have doxycycline-inducible expression of
NMDAR in the mammary fat pad (Aim 1). The NMDAR-positive models will first be used to immunize mice with
NMDAR and isolate NMDAR-reactive antibodies by single-cell RNA sequencing of intratumoral B cells.
Recombinant expression of candidate NMDAR-reactive antibodies will be used to generate cryo-EM models of
antibody-receptor complexes, thereby screening for antibody-induced structural changes (Aim 2). Finally,
candidate anti-NMDAR antibodies with low predicted pathogenicity due to minimal structural effects will be used
to treat mice with NMDAR-positive orthotopic tumors to elucidate maximal therapeutic efficacy and minimal
toxicity (Aim 3). In preliminary data generated for this proposal, we have performed a proof-of-principle
experimental sequence demonstrating that doxycycline treatment in vivo is sufficient to induce NMDAR
expression in 4T1-NMDAR tumors and elevated anti-NMDAR antibody titers in plasma. scRNA-seq of
intratumoral B cells, was enriched for NMDAR binders and we have identified multiple sequences with high-
affinity for NMDAR, two of which were characterized by cryo-EM displaying distinct epitopes. Altogether, this
proposal will leverage anti-NMDAR antibodies as an effective and non-toxic therapy for NMDAR-positive TNBC,
addressing a key unmet need for the 40,000 patients per year diagnosed with TNBC in the USA.

Public health relevance
PROJECT NARRATIVE The proposal aims to investigate the interaction between tumors and host organisms to find new treatments for triple negative breast cancer by targeting NMDA receptor expression in the cancer cells using newly developed anti-NMDAR antibodies. The mechanistic foundation for increased anti-cancer immunity as well as neurotoxicity will be elucidated using in vivo modeling of TBNC, single cell sequencing, cryogenic electron microscopy, electrophysiology, and behavioral studies in mice. Ultimately, we aim to discover optimal anti- NMDAR antibodies with high anti-cancer efficacy and minimal neurotoxicity.